Impact of Irreversible T Cell Dysfunction on Transplant Outcomes

Project Summary
T cell-mediated rejection remains a significant barrier to improving long-term allograft survival,
underscoring the need for a better understanding of allogeneic T cell responses. Our recent
discovery that alloreactive T cells differentiate first into TCF1+Ly108+ effector precursor T (TEP)
cells, which then give rise to TCF1‒CXCR6+ terminal effectors, offers a new perspective on
eliminating undesired allogeneic T cell responses by understanding and targeting alloreactive
TEP cells. To accomplish this, we aim to induce TEP cell dysfunction by targeting essential
transcriptional, epigenetic, and metabolic regulators in T cells. Our studies revealed that
deleting the transcription factor IRF4, the epigenetic enzyme EZH2, or the glycolytic enzyme
LDHA in T cells eliminates the effector differentiation potential of TCF1+Ly108+ TEP cells,
preventing them from becoming TCF1‒CXCR6+ terminal effectors. This leads to TEP cell
dysfunction and heart transplant acceptance without the need for immunosuppressive
treatments. Furthermore, we found that transient treatment with an EZH2 inhibitor alone
achieves heart transplant acceptance. Based on these findings, we hypothesize that inducing
TEP cell dysfunction is critical for achieving transplant acceptance. To test our hypothesis, we
have outlined two specific aims. Aim 1 is to investigate whether the ablation of Irf4, Ezh2, or
Ldha induces transplant acceptance by driving “irreversible” TEP cell dysfunction. Aim 2 is to
test the hypothesis that inducing TEP cell dysfunction promotes transplant acceptance in wild-
type recipients. These studies will offer insights into the induction of TEP cell dysfunction, which
has crucial clinical implications for transplantation.

Public health relevance
Project Narrative T cell-mediated rejection remains a significant obstacle to improving long-term allograft survival, yet the underlying mechanisms remain poorly understood. Our project aims to investigate the role of alloreactive T cells in driving transplant rejection and identify potential strategies for targeting these T cells, with significant clinical implications.